Mechanisms of Fetal Skin Regeneration

The ability to regenerate complex, multi-lineage organs remains one of the key challenges in regenerative
medicine. Many mammalian organs, including the heart, digit tip, and skin, retain some ability to regenerate after
damage during neonatal or fetal development, but the ability to regenerate decreases dramatically as the animal
develops. Elucidating the mechanistic basis of this differential regenerative capacity is key to understanding the
principles of regenerative control and laying the foundation for therapeutic reactivation of regeneration after injury.
To this end, we propose to determine the genetic and molecular basis of scarless, multi-lineage regeneration
after fetal skin injury. Healing of full-thickness injuries to postnatal skin is accompanied by fibrosis (scar
formation), but injuries to fetal skin heal without scar formation, a phenomenon that has fascinated biologists for
decades, but the mechanisms behind these differences remain poorly understood.
We have overcome three technical hurdles and are now uniquely positioned to take on this challenge: (1)
We have developed a robust surgical procedure to conduct wounding in fetal mice in utero. (2) We have
optimized a cell isolation protocol to collect sufficient cells for single-cell RNA and ATAC analyses from wounded
tissues. (3) We have established a strategy for rapid, in vivo genetic manipulation directly in wild-type mice by
delivering targeted genetic cargo with viral vectors. Together, these approaches will enable us to identify and
assay a relatively large number of genes in vivo for their involvement in either regeneration or scar formation.
Furthermore, we have substantial preliminary data suggesting that injuries in fetal skin (E16.5) are healed with
regeneration of diverse cell types from multiple lineages—hair follicles, innervations, blood and lymphatic vessels,
and diverse dermal cell types—resulting in skin that is morphologically similar to unwounded skin. By contrast,
these cell types fail to regenerate properly upon postnatal injury. We have also already identified one candidate
factor—CXCL12, a postnatal wound-specific secreted factor, that inhibits regeneration when overexpressed in
fetal skin.
Building on this foundation, we propose to create comprehensive cellular and molecular atlases of fetal
vs. postnatal wound healing processes using a single-cell multiomic approach (combining single-cell RNAseq
and single-cell ATACseq) to assess both transcriptome and chromatin changes in the same single-cell. We will
then determine if the reduction of CXCL12 in postnatal wounds promotes regeneration. We will also
systematically test additional secreted factors that are unique to either fetal or postnatal wounds in their ability
to drive or inhibit multilineage regeneration in the skin. Collectively, this work will provide critical insights into how
regeneration ability is blocked or lost as an organ develops, open new research directions for studying organ-
level regeneration in mammals, and guide new therapeutic strategies that promote regenerative healing under
challenging conditions including burns and chronic non-healing wounds.

Public health relevance
Project Narrative The capacity to regenerate complex organs varies greatly at different stages of development. Using skin as a model, we aim to identify genes that can functionally drive multi-lineage regeneration or scarring responses after wounding. These results are not only important for the mechanistic understanding of regeneration, but may also provide innovative therapeutic solutions to advance treatment strategies for wound healing.